Programmable Microfluidic Perfusion Bioreactor for 3D Organoid Culture and Screening Applications

Executive Summary of Predicate SBIR Phase I Grant and Team
The overall objective of our predicate SBIR Phase I grant is to develop and validate a versatile,
programmable microfluidic perfusion bioreactor platform for 3D organoid culture and screening
applications. Nine out of ten drug candidates that demonstrate safety and efficacy in animal
testing ultimately fail in human trials. Organoids offer a more representative and cost-effective
alternative to traditional in vitro and animal models for drug screening, with the FDA Modernization
Act 2.0 enabling this data to be used in drug approvals. As such, there is currently a large and
growing unmet need for new bioreactor tools designed specifically for organoid culture.
Mosaic Engineering is addressing this need by developing the Microlab, a low-cost perfusion
bioreactor that leverages recent advances in MEMS technology to precisely drive fluids across a
standardized microfluidic consumable interface. Our microfluidic consumables follow a standard
SBS plate form factor, allowing integration into broader laboratory automation workflows. The
specific aims of the Phase I project are to: (1) build a control manifold and automation software for
microfluidic perfusion cell culture, (2) demonstrate 3D organoid differentiation with the perfusion
culture system, and (3) demonstrate pharmacological dosing effects on cardiac organoids under
perfusion.
In partnership with Bullseye Biotechnologies, we will validate this platform by demonstrating drug
testing with iPSC-derived cardiovascular organoids (CVOs) under perfusion culture. We have
already developed an automated production process for manufacturing Bullseye’s differentiation
kit and ECM patterned plate (A). We have also designed and produced a microfluidic chip with 6
organoid perfusion culture chambers with 5 addressable perfusion inlets (B). This chip attaches to
a SBS-style reagent plate which attaches to a manifold and precision pressure controller (C-D).
This system is compatible with conventional inverted microscopes (E-F). The Bullseye patterning
method produces consistent organoids (G) which can be loaded into the perfusion chip and
precisely dosed with drug candidates (H). The red outline in (B) indicates ROI shown in (H).
The proposed i-Corps team includes:
Frank Myers, PhD CEO & PI/PD
Debkishore Mitra, PhD Technical Lead
Oscar Abilez, MD, PhD Industry Expert
All three team members are fully committed to meeting the time-intensive requirements of the
training program (minimum 25 hours per week per team member) and attending all scheduled
program events and webinars.

Public health relevance
PROJECT NARRATIVE Given the enormous cost of bringing new drugs to market, and the many challenges associated with evaluating drug candidates using in vitro and animal models, there is much interest in leveraging stem cells to produce organoid models of various human organ systems for drug screening. A key component of this effort is mimicking the mass transport and microenvironmental properties of natural tissues and capillaries. This study will prototype and validate a versatile, programmable microfluidic organ-on-chip bioreactor platform for perfusion culture and drug screening with vascularized cardiac organoids, leveraging a low cost electronic automation manifold and SBS-format injection-molded microfluidic consumables.